Hormonal Regulation of Liver Metabolism

Summary/Abstract
Non-alcoholic fatty liver disease (NAFLD) represents a spectrum of excess fat accumulation in the liver
(steatosis) without or with inflammation/fibrosis (non-alcoholic steatohepatitis - NASH). NAFLD is commonly
observed in obesity and type 2 diabetes, but is also observed in non-obese patients associated with
cardiovascular disease. To date, there are no proven medical therapies to reverse NAFLD. In order to develop
effective treatments, it is critical to understand the basic mechanisms controlling hepatic fat accumulation and
associated liver damage. Since both clinical and experimental studies demonstrate hepatic growth hormone
(GH)-signaling is reduced in NAFLD and increasing GH can reduce NAFLD both in humans and mice, our recent
work has focused on determining how GH mediates these effects. We have used unique mouse models with
adult-onset loss of the hepatocyte GH receptor (GHR) and demonstrated GH signaling controls steatosis by
suppressing de novo lipogenesis (DNL), an action of GH not previously appreciated. Additional preliminary data,
coupled with published reports, led us to formulate the HYPOTHESIS: GH directly controls hepatocyte DNL via
GHR/Stat5b-mediated regulation of glycolysis, to protect the liver from injury. The following Specific Aims (SA)
will test this hypothesis. SA1 - Determine if the GHR signals through Stat5 to directly suppress hepatic
DNL and prevent NAFLD progression. Expt SA1A, will determine if enhancing Stat5b activity can suppress
DNL and prevent NAFLD by expressing a constitutively active form of Stat5b (Stat5bCA) in mice lacking the
hepatocyte GHR. Since Stat5b enhances hepatic IGF1 expression and raises circulating IGF1 levels, Stat5bCA
will be expressed in mice with combined knockdown of hepatocyte GHR and IGF1, to determine what actions of
Stat5b are IGF1-independent. Expt SA1B, will establish if GHR-mediated Stat5b activation is required to control
DNL, by expressing a mutant GHR in the hepatocyte of adult mice lacking the endogenous GHR, where this
mutant receptor cannot activate Stat5b, but can active other JAK2-dependent and independent pathways. In a
subset of mice, hepatocyte IGF1 expression will be reconstituted, to prevent secondary changes due to IGF1
loss. SA2 – Determine if loss of hepatocyte GHR/Stat5b signaling acts independent of canonical insulin
signaling to augment glycolysis-driven DNL. Expt SA2A, will determine if hepatocyte GHR loss and
restoration of Stat5b activity regulates glycolytic flux and DNL when insulin and carbohydrate input to the liver is
controlled, by assessing [1-13C] glucose enrichment of glycolytic, TCA intermediates and newly formed fatty
acids, under hyperinsulinemic-hyperglycemic clamp conditions, in mice lacking the hepatocyte GHR, without or
with Stat5bCA. Expt SA2B, will establish if the glycolysis-mediated transcription factor, Chrebp, is required to
enhance DNL, steatosis and liver injury after hepatocyte GHR loss, by generating mice with adult-onset,
hepatocyte knockdown of both Chrebpα and GHR. Completion of these studies will enhance our basic
understanding of the mechanisms by which GH directly controls hepatocyte carbohydrate/lipid metabolism and
protects the liver against injury, with the ultimate goal of unveiling novel “druggable” targets to treat NAFLD.

Public health relevance
Project Narrative Nonalcoholic fatty liver disease (NAFLD) is associated with an increased flow of lipids from the periphery to the liver, as well as an increase in the ability of the liver to make new lipids from glucose (de novo lipogenesis, DNL). Obesity/NAFLD is associated with low levels of circulating growth hormone (GH) and insulin-like growth factor I (IGF-I), and the fatty liver becomes resistant to the actions of GH. Our preliminary data demonstrate that a liver-specific loss of the GH receptor in mice increases DNL and enhances the capacity of the liver to accumulate fat, ultimately leading to liver injury. Therefore, GH works directly on the liver to control excess fat accumulation and protect the liver from damage. Given the translational relevance of our findings, studies are proposed to determine the molecular and biochemical pathways that are regulated by GH to control liver- specific lipid production and accumulation, which could represent future drug targets to prevent and treat NAFLD.